PROJECT 2: NF1-associated Glioblastoma

ABSTRACT (Project 2)
Our central hypothesis is that NF1 mutant gliomas constitute a distinct glioma subgroup with a unique
molecular pathogenesis, tumor microenvironment, and tumor cell vulnerabilities. Our approach includes a
variety of glioma models, including GEMs, patient-derived xenografts (PDX), primary cultures, and human
tumor biopsies. We will consider both germline and somatic NF1 silencing, and also build upon the
considerable recent progress with targeting NF1 associated tumorigenesis in other organ systems (Projects 1
and 3) to maximize the translational impact of this work. To develop NF1 genotype-specific hypotheses,
syngeneic GEM and derived GBM primary cultures are our first choice for discovery aspects of cell intrinsic
properties, as well as the immune microenvironment and first line therapeutic testing. We will exploit mouse
models developed by us that spontaneously develop GBM with full penetrance by inactivating three key tumor
suppressor genes in this disease (NF1, Tp53 and Pten) and engineered to mimic germline versus somatic NF1
driven disease. In one setting the mice harbor a heterozygous germline NF1 mutation (NF1-/flox or -/+), whereas
in the other setting the mice will develop only somatic NF1 mutations (NF1flox/+ or NF1flox/flox). Mice that develop
GBM due to mutations in the QKi, Tp53 and Pten genes (QPP mice) will serve as controls in these
experiments and represent the subgroup of NF1 wild type GBM. Primary cultures and expanded tumor
allografts will be used for in vitro and in vivo preclinical studies. Since the genetic complexity of sporadic GBM
in humans is not adequately represented in GEM, we will confirm and extend key results in PDX models that
vary in genotypes but for which the NF1 gene is either mutated or wildtype. NF1 mutant and NF1 wild type
patient derived orthotopic xenografts (PDX) developed at MSKCC will be studied in alignment with Projects 1
and 3, to test NF1/Ras pathway-tailored and other therapies that have emerged in the field. Human tumor
samples are most relevant for assessment of immune infiltration and will be examined in context of the unique
clinical presentation of patients with germline NF1 GBM. Aim 3 will focus on the systematic clinical annotation
of patients with germline NF1 GBM paired with detailed histologic and molecular analysis of routinely collected
formalin-fixed and paraffin embedded tumor biopsies from people with NF1 associated GBM. These studies
will be performed in collaboration with Core C (Biospecimen/Pathology) and will be used to validate key results
regarding NF1 associated characteristics of the TME. We will collaborate with Core B (Omics) to perform
detailed genomic and proteomic characterization of samples from GEM, PDX and human tissue to identify
actionable signaling pathways specifically in NF1 mutant GBM. A patient-facing portal will be created to recruit
and systemically document the clinical presentation and course of NF1 associated GBM to allow integration of
histologic, molecular and clinical data for NF1 driven gliomas across GEM and PEX preclinical models and
people with NF1 GBM.

Public health relevance
NARRATIVE (Project 2) Individuals with NF1 have a high incidence of glioma. Also, the NF1 gene mutation is present in approximately 20-25% of sporadic high-grade gliomas. These NF1 mutant gliomas are aggressive and have no effective treatments. Through the use of sophisticated experimental models and molecular profiling of clinically annotated patient tumor biopsies, we will explore unique features of NF1 mutant gliomas also leveraging recent advances in PNST treatment.